9th Annual International Conference of Aldosterone and ENaC

PROJECT SUMMARY/ABSTRACT This proposal seeks support for a travel award program for the American Physiological Society (APS) conference “Aldosterone and ENaC in Health and Disease: The Kidney and Beyond,” scheduled October 2-6, 2019, in Estes Park, Colorado. This is the 9th in a series of highly successful conferences that have been held every 3-4 years. The overall goal of this conference is to bring together basic, clinical, and translational scientists to present and discuss new research and ideas related to aldosterone, the mineralocorticoid receptor, and the epithelial sodium channel (ENaC) and other relevant ion transport proteins. Aldosterone and ENaC play critical roles in diseases that affect millions of adults, including hypertension, heart failure, atherosclerosis and renal failure. Thus, work discussed at this conference will advance our understanding of the basic biology of these molecules and their roles in physiology and disease. The conference objectives are to 1) Bring together experts in basic, clinical, and translational research related to aldosterone/mineralocorticoid receptor (MR) and the epithelial sodium channel (ENaC), and related areas, for an intensive multi-day conference. Participants will present and discuss the latest cutting-edge research in these fields, outline future directions, explore areas of common interest, and establish new collaborations to move these fields forward. 2) Facilitate participation and career development for trainees, early career investigators, and underrepresented groups. This will be accomplished through the awarding of travel funds, the targeted selection for oral presentations, outreach to identify a diverse group of participants, and logistical programs to facilitate participation of individuals with disabilities or family care needs. 3) Develop interest in the investigation of aldosterone/MR, ENaC, and related areas, by new investigators and other investigators with diverse perspectives who will bring novel ideas and approaches to these fields. This will ultimately lead to new breakthroughs for aldosterone- and ENaC-related diseases. To achieve these objectives, the organizers have developed a program that includes symposia focused on cutting-edge topics related to aldosterone/MR and ENaC (and other relevant channels/transporters), keynote and plenary lectures, poster sessions, and formal and informal career development activities. We have placed an emphasis on providing numerous opportunities for trainees, early career investigators, and members of underrepresented groups to present their work and receive feedback and mentoring. To facilitate their participation, we propose an NIH-funded travel award program.

Public health relevance
PROJECT NARRATIVE This proposal seeks support for a travel award program for the American Physiological Society (APS) conference “Aldosterone and ENaC in Health and Disease: The Kidney and Beyond.” This conference will bring together basic, clinical, and translational scientists to present and discuss new research and ideas related to aldosterone, the mineralocorticoid receptor, and the epithelial sodium channel (ENaC) and other relevant ion transport proteins. Aldosterone and ENaC play critical roles in diseases that affect millions of adults, including hypertension, heart failure, atherosclerosis and renal failure. Thus, work discussed at this conference will advance our understanding of these diseases and will provide the basis to develop more effective treatments.